Metalloenzyme structure, function and assembly

Abstract
The combination of metal ions with proteins offers unique chemical reactivities, which are at the heart of many
of Nature's most amazing chemical transformations. My laboratory interrogates how metalloenzymes harness
the reactivity of supernucleophiles and radical cofactors, while protecting themselves from potential damage. It
is an incredibly exciting time to be studying metalloenzymes. Bioinformatics and genomic studies are
identifying new putative metalloenzymes at a dizzying pace, with more than 100,000 unique sequences now
associated with the Radical S-adenosylmethionine (SAM) enzyme family alone. Characterization of these
enzymes is revealing unprecedented chemistry and new cofactor-binding structural motifs. Impressively, many
of these Radical SAM (RS) enzymes are part of biosynthetic pathways that produce natural products with
novel molecular scaffolds and promising pharmaceutical properties (including antibiotic, antiviral, and anti-
tumor properties). My laboratory is employing our favorite technique of X-ray crystallography to probe
sequence space within this family with the goal of understanding how RS enzymes harness radical-species to
perform chemically challenging reactions. In the next five years, we will leverage recent success and continue
to investigate the structure/function of cobalamin-dependent RS enzymes. This 7000-membered RS subgroup
represents a new set of challenges and opportunities to understand how Nature tunes and controls both radical
and supernucleophile reactivities. It is not only the RS enzyme family that has been in the spotlight recently;
the glycyl radical enzyme (GRE) family is also receiving increased attention. In this latter case, the human
microbiome project is providing new information as to the importance and abundance of GREs in the human
gut and oral cavities. For example, the most abundant uncharacterized enzyme found in the gut is a GRE! In
the next five years, we plan to investigate several newly discovered members of the GRE family that appear to
be key players in human microbial communities. Our goal is to use our structural tools to interrogate the
molecular basis for the radical-based chemistry that contributes to microbial metabolism, and potentially
pathogenesis, in the human gut. A number of these GREs are found in common pathogens, like C. difficile,
and are potential drug targets. Finally, it is a great period to be working on the “great clusters of life,” which are
responsible for the fixation of carbon (C-cluster/A-cluster), nitrogen (MoFe cluster) and hydrogen (H-cluster).
My laboratory focuses on carbon fixation and the C- and A-clusters of carbon monoxide dehydrogenase/acetyl-
CoA synthase. Recent advances have afforded recombinant systems that are allowing us to probe cluster
assembly, reaction mechanism, and oxygen-sensitivity in a manner that was not possible previously. Oxygen-
sensitivity is the Achilles heel of a complex metalloprotein and we plan to use our structural toolbox to
investigate the molecular basis of C-cluster oxygen-sensitivity.

Public health relevance
Narrative Understanding and being able to manipulate metalloenzyme biochemistry has applications for many aspects of human health and biotechnology (e.g. the production of novel antibiotics and anticancer drugs, sustainable biofuel production, and environmental toxin remediation). With both antibiotic resistance and climate change emerging as major health concerns, the proposed studies are important and timely, and the efforts will result in insights necessary to these frontier challenges.